Impact of aging on human B cell vaccine responses

PROJECT SUMMARY
As humans age, their immune systems become dysfunctional. Specifically, aging impacts adaptive immunity
leading to reduced response to vaccines. A productive immune response to vaccines is characterized by high
affinity antibodies and an increase in antigen-specific memory B and T cells. Intense research efforts have
determined the role of T cells in aging; however the role of B cells is less clear. We hypothesize that humans,
like mice, have age-related B cells (ABCs) in blood that can be tracked by clonal expansion, and in
within tissue, outcompete important tissue specific B cell types, therefore limiting the capacity of older
adults to respond to vaccines. We have assembled a team that span topic areas and technical expertise to
address difficult questions of human B cell dysfunction with age. We utilize longitudinal and cross-sectional
design to assess B cell aging in blood and lymphoid tissues. Further, we leverage a novel in vitro human tonsil
organoid model we developed that allows mechanistic testing of age-induced B cell decline of vaccine
responses, a feat previously impossible. In Aim 1, we will identify human ABCs by mapping dysregulation of
phenotypic and functional B cell signatures over time. We hypothesize that ABCs are memory B cells that
accumulated epigenetic changes, leading to a transcriptional program consisting of muted BCR
responsiveness, dysregulated expansion, and defective function. We will analyze peripheral blood B cells and
serum from a healthy aged longitudinal cohort using high-parameter flow cytometry and bulk RNA sequencing
and multiplexing to track changes in B cell subsets, transcriptional profiles, BCR repertoires, and cytokine and
antibody secretion. In Aim 2, we will target age-related mechanisms of lymphoid tissue B cell dysfunction to
improve effective flu vaccine responses. ABCs are thought to derive from expansion of memory B cells.
Therefore, we hypothesize that lymphoid tissues with high antigen exposure will have higher prevalence of
ABCs and increased signatures of aging. Furthermore, we anticipate that targeting ABCs using a human tonsil
organoid platform will improve flu vaccine responses. With unparalleled access to multiple post-mortem
lymphoid tissues, we will compare B cells from young and older adults. We will use high parameter flow
cytometry to enumerate B cell populations and perform single cell RNA sequencing on sorted B cells across
human blood and tissues. Additionally, we will assess metabolism and cytokine secretion of aging B cells
across tissues using extracellular flux analysis and multiplex cytokine profiling. Lastly, we will use a novel in
vitro human tonsil organoid model to determine the cellular and molecular mediators of impaired vaccine
responses. Understanding how age impacts B cell function will allow for improvement of vaccine design to
increase B cell antibody responses, and therefore better protect the aging population of the world.

Public health relevance
PROJECT NARRATIVE The population of the world is aging. Age impacts the body’s response to vaccines by reducing the quality and quantity of antibodies which are the main way vaccines provide protection from infectious disease. This proposal will study how aging affects B cells, the cells that make antibodies, therefore allowing the development of better vaccines.